Optimization of biliverdin IXβ reductase redox inhibitors as novel reagents for enhancing platelet production

Program Director/Principal Investigator (Last, First, Middle): NESBITT, Natasha M..
PROJECT SUMMARY/ABSTRACT
This Phase II SBIR proposal will support our ongoing drug discovery program designed to develop and validate
small molecule inhibitors of a novel drug target regulating platelet production in humans. The scope of work
builds on strong genetic and biochemical evidence linking redox-dependent enzymatic activity of biliverdin IX
reductase (BLVRB) in a previously-uncharacterized regulatory pathway of megakaryocyte development and
enhanced platelet production. In silico virtual screening with our novel scoring function led to the identification of
~20 compounds predicted to inhibit the redox activity of BLVRB. Biochemical and cell-based assays validated
four of these compounds as potent inhibitors of the enzyme. A complementary crystallographic assay led to the
identification of two additional compounds with increased potency towards BLVRB. We will employ medicinal
and computational chemistry to optimize our hit compounds to develop lead compounds with improved potency
and selectivity for BLVRB. These compounds will be further characterized using in vitro hematopoietic assays
and follow up in vivo animal studies to show improved efficacy in comparison to our current hit compounds.
Long-term success of this project is predicated on synergistic expertise in computational chemistry, platelet
biochemistry, crystallography, and drug discovery. Successful completion of the research proposed in this grant
has fundamental relevance to commercial development of a new class of platelet enhancing compounds
functioning independently of the known thrombopoietin (TPO)/c-MPL receptor axis. Compound development and
target validation provide a highly innovative strategy that would theoretically bypass toxicities associated with
direct TPO/c-MPL agonists currently in clinical use (such as platelet activation, thromboembolic complications,
and bone marrow fibrosis), while generating first-in-class redox inhibitors for further pre-clinical development.
PHS 398/2590 (Rev. 06/09) Page
Continuation Format Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): NESBITT, Natasha M.. PROJECT NARRATIVE/PUBLIC HEALTH RELEVANCE Human blood platelets stop bleeding, and low platelet counts cause life-threatening hemorrhage. Approaches to temporarily correct low platelet counts include platelet transfusions from donors (difficult to obtain and costly), and medications which are known to be associated with platelet activation, blood clotting, worsening platelet counts and bone marrow scarring. The approach taken in this Phase II SBIR grant builds on our efforts to develop a new class of compounds for a highly novel drug target identified in our laboratory that regulates platelet counts in humans. The applicant small business organization Blood Cell Technologies was specifically developed for early stage R&D focusing on commercial development of diagnostics and therapeutics important for human blood diseases. A drug development program targeting a distinct oxidation reduction reaction represents an innovative platelet-enhancing strategy unrelated to previous drug targets. The scope of work builds on strong genetic evidence linking the enzymatic function to enhanced platelet counts in humans, identifies a novel pharmacologic target for development, and represents a new mechanism of action that may have broader implications for redox biology in blood formation. Successful completion of the research has fundamental relevance to commercial development of a new class of compounds that enhance platelet counts in humans. PHS 398/2590 (Rev. 06/09) Page Continuation Format Page